Deciphering the crosstalk between bacteria and their mammalian hosts

PROJECT SUMMARY
The commensal bacteria that inhabit our microbiomes have a direct impact on human health. Recent studies
have shown that bacteria in the gut can even alter patient responsiveness to immune checkpoint inhibitors, the
latest generation of anticancer immunotherapy. The mechanisms of how bacteria influence the immune
response to cancer are poorly understood; therefore, understanding bacterium-human interactions at the
molecular level is critical to our understanding of the immune system, disease, and therapeutics. An important
way that bacteria influence human cell signaling is through the production of small molecules that activate or
inhibit human cellular receptors. We are specifically focused on how diverse bacteria manipulate the
mammalian cGAS-STING pathway, a clinically relevant pathway that is critical for the immune response to
cancer, as well as viruses and pathogenic bacteria. In humans, cGAS generates a cyclic dinucleotide second
messenger that activates STING, which is the crucial step for initiating anticancer signaling. We recently made
the unexpected finding that bacteria of the gut microbiome encode enzymes homologous to cGAS. Bacterial
cGAS synthesizes cyclic dinucleotides that agonize STING, and cyclic dinucleotides released by bacteria can
be taken up by mammalian cells. Cyclic dinucleotides thus provide a molecular basis for bacteria to manipulate
the human cGAS-STING pathway and offer a shared molecular language for crosstalk between the microbiota
and mammalian cells. Although bacterial and mammalian cGAS are highly similar, there are important
differences in the heterogeneity of their cyclic dinucleotide products and studying these differences will
decipher the crosstalk between these domains of life. Mammals synthesize one potent second messenger
while bacterial cGAS-like enzymes are highly diverse. Different bacteria produce unique cyclic dinucleotide
products that vary in their ability to agonize STING and additional human immune pathways. This proposal
investigates the hypothesis that bacteria in the microbiome expressing different bacterial cGAS alleles can
alter host STING signaling, the host immune response to cancer, and the effectiveness of cancer
immunotherapy. First, we will investigate the role of specific bacteria expressing cGAS homologues in altering
effectiveness of cancer immunotherapy. Next, we will interrogate known bacterial strains that alter patient
responsiveness to cancer immunotherapy for production of cyclic dinucleotides. Finally, we will explore the
human immune pathways, including STING, that are activated by the full range of diverse cyclic dinucleotides
synthesized by bacteria. This proposal is focused on the mechanisms by which bacteria alter patient
responsiveness to cancer immunotherapy; however, I expect results from these studies to be broadly relevant
to our understanding how specific bacteria in the human microbiota influence human health and will advance
the clinical utility of cyclic dinucleotides as therapeutic agents.

Public health relevance
PROJECT NARRATIVE Patient responsiveness to cancer immunotherapy varies widely between individuals and is associated with the bacterial inhabitants of the gut microbiome, but the mechanism is not understood. Recent evidence suggests the cGAS-STING immune pathway also plays a crucial role in activating anticancer signaling and we have found that gut-associated bacteria produce signaling molecules that activate with this pathway. This project investigates how bacteria in the microbiome manipulate cGAS-STING signaling, thereby enabling future development of better anticancer therapeutic agents.